Intergenerational Adversity Exposure and Language Acquisition

PROJECT SUMMARY/ABSTRACT
Approximately 65% of the United States population reports at least one adverse childhood event. A third of
adversity-exposed youth do not meet age expectations for language, which is triple the rate of developmental
language disorders in the general population. A critical area of interest for interventions is the role of parent-
mediated language input, characterized by the quantity and quality of parent talk directed toward the child.
Researchers often focus on socioeconomic status (e.g., parental education) as the primary environmental
influence on parent-mediated language input. In contrast, this interdisciplinary study posits the novel construct
of adversity exposure, emphasizing the role of intergenerational pathways. Specifically, the parent’s own history
of childhood adversity is included in the model as a predictor of parent-mediated language input while also
applying a genetically-informed design. This study will leverage an existing dataset of 325 preschoolers who
have histories of extensive adversity exposure and were followed longitudinally for two years. Using video-
recordings of a semi-structured free play task, parent-child interactions will be transcribed and coded for
language sample analysis. The aims of this project are to a) determine the impact of adversity exposure on
parent-child linguistic interactions, and b) examine intergenerational effects on parent-mediated language input
and child language outcomes. By elucidating the pathways linking adversity exposure and language acquisition,
this study will determine an additional environmental factor beyond socioeconomic status that may serve as a
risk factor for delayed or impaired language. Further, this study will inform the foundational knowledge used to
devise increasingly effective and efficient language intervention frameworks and strategies.

Public health relevance
PROJECT NARRATIVE This project will determine whether adversity exposure impacts parent-child linguistic interactions and how the parent’s own childhood history of adversity influences language use with their child. Using observational methods, this project will clarify the role of the parent’s language input on child language outcomes within an intergenerational framework.